Engagement Core

Engagement Core
Project Summary/Abstract
The unifying themes of the Engagement Core are (1) facilitation of bidirectional engagement with the
community by all Center investigators, (2) removal of barriers to equitable access to services for all children
with SLDs, (3) translation and dissemination of the results of the CLDRC to families, scientists, practitioners,
and policy communities, and (4) development of project-based career-enhancing opportunities for CLDRC
mentees and engaged members of the community. Core objectives will be accomplished by facilitating access
to comprehensive SLD assessments for families who would not otherwise be able to afford these services,
developing individualized mentorship plans and implementing an equitable publication plan that ensures that
mentees have opportunities to serve as lead and corresponding authors, and facilitate bidirectional sharing of
knowledge with the community by all CLDRC investigators, including support for specific skill development for
community members who are engaged with the CLDRC.